Impact of local and systemic cellular senescence toward Triple Negative Breast Cancer growth and drug therapy

ABSTRACT
Triple negative breast cancer is considered one of the most aggressive forms of breast cancer and efficacious
treatment options are lacking. A potential therapeutic avenue is related to senescent cells. Cellular senescence
engages in important roles for many aspects of tissue homeostasis. As the natural process of aging occurs
along with stresses and insults from the environment, cells in various organs and tissues of the body can
undergo senescence, a phase of arrested growth and exit from the cell cycle that is established in order to
prevent further propagation of damaged cells. A defining feature of senescent cells is their senescence-
associated secretory phenotype (SASP), a group of cytokines, proteases, and growth factors, which are
thought to recruit cells of the immune system to clear out damaged cells. Length of exposure to the SASP
impacts what happens to the microenvironment. During embryonic development, wound healing, suppression
of tumor growth, and recruitment of immune cells, short-lived, reversible senescence of defined cell
populations and the resultant SASP promote optimal fitness for the organism. On the other hand, when
senescent cells are present chronically, the SASP can have more negative effects, which include promoting an
environment for tumorigenesis and metastasis. In terms of TNBC, no known studies have been carried out that
assess how senescence and the SASP impact TNBC progression.
In my preliminary studies, I have utilized the ATTAC mouse model (=Apoptosis through Activated
Caspase 8). In this model, senescent cells express a drug-inducible suicide gene cassette under the control of
p16Ink4a regulatory sequences. When given an inducing drug, AP20187, senescent cells expressing p16ink4a are
eliminated by apoptosis. Thus, the first aim of my grant is to assess the effect of local and systemic senescent
cells on growth and metastasis of the syngeneic TNBC cells in the ATTAC mice as hosts. The preliminary data
suggest that continuous clearance of host senescent cells results in reduced tumor growth. Based on this,
under a second aim I wish to analyze the impact that senolytics (drugs that eliminate senescent cells) have on
the efficacy of cancer therapeutics (i.e. immune checkpoint inhibitors) towards TNBC. No known studies have
yet been done that look at the relationship between immune checkpoint inhibitors and senescence towards
TNBC. Thus, completion of these aims will provide not only insight on how TNBC growth is affected by both
the microenvironment and the system as a whole, but also the possibility of discovering unique
pharmacological targets for more effective TNBC treatments.

Public health relevance
NARRATIVE Cancer is one of the leading causes of death in the world, with senescence playing a unique role in tumor growth or progression. I propose to assess how cellular senescence affects triple negative breast cancer growth along with how they impact the efficacy of cancer therapeutics through use of a unique in vivo senescence model. With this knowledge, an optimal goal of discovering therapies that utilize senescent cells and provide greater efficacy, reduce recurrence risk and offer better prognostic outcome will be achieved for triple negative breast cancer treatment.